From here to eternity: gut microbial response to drug therapy and inflammation

ABSTRACT
The genomic revolution has provided us with an “embarrassment of riches” with respect to our understanding of
the composition of gut microbial communities in disease, but we are still far from understanding how microbial
genes and pathways impact host health. While a wealth of studies show that the microbiome is associated with
disease states, we know little about the microbial genes that respond to disease-associated perturbations, such
as inflammation or drug therapy, and how these microbial responses contribute to disease and drug response.
Lack of knowledge of how microbial genes respond and contribute to disease-associated perturbations limits our
ability to rationally design microbiome-targeted therapies, such as fecal microbiota transplant, live
biotherapeutics, and small molecule microbial inhibitors. My lab’s long-term goal is to understand how the
microbiome contributes to the resolution of systemic inflammation. The overall objective of this R35 NIGMS
MIRA grant is to support the aspect of my research program focused on deciphering the microbial genetic
determinants of responses to inflammation and drug therapy and how these impact the host. With the support
of the R35 MIRA grant, over the next 5 years, I aim to establish a unique and productive niche at the intersection
of microbiology, genetics, and systemic inflammatory disease by investigating the following key questions /
themes: (1) which microbial genes are important for responding to host inflammation and drug treatment, (2)
how do these microbial genes subsequently contribute to host inflammation, and (3) can drugs targeting specific
microbial genes impact gut microbial ecology and evolution in the setting of host inflammation. The proposed
research program seeks to fill these knowledge gaps by harnessing cutting-edge technologies and my unique
backgrounds in computer science, genomics, microbiology, clinical immunology, and gnotobiology. The human
gut microbiome is with us “from here to eternity” but we are just beginning to uncover the powerful forces in vivo
that shape the microbial community and its evolution. The microbial genetic basis of these shifts in the setting of
inflammation and drug therapy is not commonly studied; filling this fundamental knowledge gap will pay dividends
in the future by improving the efficacy of therapeutic strategies that are currently underway in patients with
inflammatory disease.

Public health relevance
NARRATIVE The microbes in the gut can contribute to disease and inflammation, but we lack fundamental knowledge about how microbial genes impact inflammation or treatment. We plan to use new state-of-the-art genomic technologies to understand how gut microbes respond and contribute to inflammation. This information will be critical to more effectively design new therapies that target the microbes in our gut.